Mathematical investigation of dynein-mediated centrosome positioning in polarized cells

Project summary/Abstract: Cells live in noisy environments and must integrate multiple biochemical, mechan-
ical and geometric signals during development. Cells use these signals to make critical decisions such as de-
termining the orientation of the division plane. Orientation of the division plane is dictated by the position of
centrosomes, small nucleus-associated organelles that nucleate microtubule (MT) arrays. MTs interact with the
motor protein dynein, and the forces generated by these interactions position the centrosomes. In polarized cells,
where speciﬁc factors are segregated to distinct areas of the cell, centrosome positioning is especially important:
centrosomes aligned along the polarity axis of the cell will produce unequal daughter cells (asymmetric division,
involved in cell fate speciﬁcation), while centrosomes oriented orthogonal to the polarity axis will produce identical
daughter cells (symmetric division, associated with proliferation). Impaired centrosome positioning can also be
a hallmark of disease states: cancer cells often exhibit abnormal centrosome positioning. In this project, we will
demonstrate that biochemical, mechanical, and geometric signals act interdependently to position centrosomes in
polarized cells prior to division. We will investigate the role of these features using mathematical modeling, which
can deal with complex multiscale interactions. To ensure biological realism, we will experimentally test our models
using early embryos of the nematode worm Caenorhabditis elegans, which polarize and orient their centrosomes
along the long axis of the cell resulting in an asymmetric ﬁrst division. The proteins involved in polarization and
centrosome positioning are highly conserved across organisms, making insights applicable to other biological
contexts. To determine the role of biochemical signaling, we will develop a model that tracks spatial and temporal
protein dynamics, producing patterns over long space scales as a result of fast, local interactions. We will test the
model by perturbing protein localization and quantifying changes in dynein localization or centrosome movement.
We have observed mechanical asymmetries in the centrosome-associated MT arrays. We will determine the
origin and consequence of this mechanical asymmetry by developing a model of centrosome maturation, which
takes place over short time and space scales. We will compare model results to ﬂuorescent protein dynamics
during centrosome maturation, and use a novel ﬂuorescent protein timer to determine if this asymmetry is related
to centrosome age. To investigate the role of cell geometry, which operates over large time and space scales, we
will use a biologically based whole cell model along with simpliﬁed energy models to determine the most favorable
centrosome position over a range of volume and aspect ratio values. We will experimentally perturb the size and
shape of the embryos to demonstrate whether geometry alone can induce or compensate for defects in force
generation during centrosome positioning. The powerful combination of theoretical and experimental approaches
will yield a fundamental understanding of dynein-mediated centrosome movement in response to biochemical,
mechanical and geometric features.

Public health relevance
Project narrative: Proper centrosome positioning is critical during development, and is regulated by highly conserved biochemical, mechanical and geometric cues. This project utilizes theoretical and experimental ap- proaches spanning small scale molecular interactions to cellular scale organization to elucidate the mechanisms regulating centrosome positioning prior to mitosis. Since proper centrosome positioning is critical for a variety of developmental processes, this understanding could lead in the long term to comprehensive identiﬁcation of defects due to impaired centrosome positioning and development of targeted therapies.